Identifying Stigma Reduction Targets in the Context of an Appalachian HIV Outbreak

PROJECT SUMMARY/ABSTRACT
This study will examine how drug-related stigma influences the utilization of HIV prevention and testing
programs among people who inject drugs (PWID) in the context of ongoing HIV outbreaks in Appalachia. The
opioid crisis has contributed to high levels of injection drug use in rural communities, leaving them highly
vulnerable to HIV outbreaks. Scaling up evidence-based HIV prevention and testing programs is critical for
averting these outbreaks but even where these programs exist, often they are not used by PWID. Drug-related
stigma may pose a substantial barrier to engaging in these services, especially in rural communities where
anonymity and confidentiality are difficult to maintain. However, there is limited research on how drug-related
stigma and its individual constructs (e.g., enactedstigma, anticipated stigma, internalized stigma) affect
program uptake among PWID. Our study will used a sequential mixed methods approach to fill these
knowledge gaps by (1) exploring the ways in which stigma influences the utilization of HIV prevention and
testing programs among rural PWID, (2) adapting and validating an existing stigma scale, the Substance Use
Stigma Mechanisms Scale (SU-SMS), for rural PWID, and (3) characterizing the types and sources of stigma
that serve as barriers to HIV prevention and testing program participation in this population. The study will be
conducted at two sites in West Virginia, which is the location of ongoing HIV outbreaks fueled by injection drug
use. In Phase I of the study, we will conduct qualitative interviews with PWID (N=40) and healthcare providers
(N=24) to provide insight into how stigma is operationalized in the context of HIV services utilization. In Phase
II, we will conduct a survey of PWID (N=300) to adapt and validate the SU-SMS. Then, we will model the
association between individual stigma constructs and HIV prevention and testing program use while also
considering other structural- and individual-level factors that influence healthcare utilization. The resulting
information will assist us in targeting, developing, and testing novel stigma-reduction interventions designed to
improve rural PWID engagement in HIV prevention and testing services, with the ultimate goal of reducing HIV
transmission among PWID in rural communities.

Public health relevance
PROJECT NARRATIVE Improving the uptake of HIV prevention and testing services among people who inject drugs (PWID) is critical in rural communities that are highly vulnerable to injection-related HIV outbreaks. This study will examine how drug-related stigma influences the use of HIV prevention and testing services among PWID in rural Appalachia by testing a new tool to measure drug-related stigma and characterizing how different types of drug-related stigma affect program participation. The study findings will inform the development of innovative stigma- reduction interventions designed to improve program participation and ultimately reduce injection-related HIV transmission in rural communities.